Core B: Biostatistics & Bioinformatics

Core B Abstract
Core B, Biostatistics & Bioinformatics, will be led by Joseph G. Ibrahim, Ph.D., Joel S. Parker, Ph.D., and
Steve Marron, Ph.D. The services of this Core include RNA and DNA sequence data management and
analysis, biostatistics, methodological development, and computational infrastructure. The capabilities in this
arena at UNC Lineberger and the UNC Gillings School of Public Health are nation-leading. This SPORE Core
is the most closely allied with the LCCC Bioinformatics Shared Resources and builds upon its strengths. Core
B will consist of investigators from the LCCC Bioinformatics Shared Resource led by Dr. Joel Parker, and the
LCCC Biostatistics shared resource lead by Dr. Joe Ibrahim. Core B bioinformatics will be co-led by Joel
Parker and Steve Marron, and assisted by Andrew Nobel and Katherine Hoadley. This group has developed
and applied data processing and analysis methods that are widely used across the world. Drs. Hoadley and
Parker remain key participants in the broader TCGA project having been vital authors on multiple TCGA
papers. Senior statisticians Drs. Marron and Nobel began working on genomic analysis in 2001, and have
been involved in analytic and methods development ever since. They are closely collaborative with the head of
the LCCC Biostatistics Shared Resource, Joe Ibrahim, PhD. He has led this Core for the past 5 years, and
biostatistician Dr. Bahjat Qaqish has been involved in this SPORE since the initial 1992 submission. Additional
key biostatistics personnel including Naim Rashid, who bring expertise in genomics and ChIP-seq to this Core.
The combined experience and ability of the LCCC Biostatistics and Bioinformatics Shared Resources will be
available to all projects in this SPORE. The funding for this SPORE Core B is for specific participation in the
four projects and to provide advice and analysis capabilities to Career Awardees and those developing pilot
projects.

Public health relevance
Core B Project Narrative Cancer biology and clinical medicine are increasingly dependent upon the management and analysis of data from sequencing, imaging, and mass spectrometry. These technologies for genomic and proteomic measurement create large, complex, and heterogeneous data that must be integrated with pathological and clinical data. The coordinated analysis of these multiple data types requires a highly sophisticated, facile, and rigorous bioinformatics and statistical infrastructure. Core B brings together computational, informatics, and biostatistics expertise to overcome these challenges and advance our biological understanding and clinical treatment of breast cancer.